Cutaneous Phosphorylated Alpha-Synuclein for Detection of Prodromal Synucleinopathies

PROJECT SUMMARY
A group of devastating diseases, collectively termed synucleinopathies, affect over 2 million people in the U.S.,
carry significant morbidity, high mortality and enormous associated health care costs. Synucleinopathies are
characterized by the abnormal deposition of a misfolded protein, phosphorylated α−synuclein (P-SYN), within
the central and peripheral nervous systems. Synucleinopathies include Parkinson’s disease (PD), dementia with
Lewy bodies (DLB), multiple system atrophy (MSA) and pure autonomic failure (PAF) differ in clinical symptoms
and disease progression rates. Currently, no disease modifying therapies exist for any of the synucleinopathies.
Deposition of P-SYN within the cutaneous (skin) nerve fibers of synucleinopathy patients provides diagnostic
clarity and increases with disease progression. Importantly, cutaneous deposition of P-SYN is also observed in
the majority of patients diagnosed with idiopathic rapid eye movement sleep behavior disorder (iRBD), a prodro-
mal synucleinopathy in which >90% of patients phenoconvert to clinically apparent synucleinopathy within 15
years of diagnosis. At present, methods for determining the disease trajectory of clinically apparent synucle-
inopathy in patients with iRBD do not exist. Diagnostic tools able to evaluate and reliably predict the probability
of phenoconversion at prodromal stages is an urgent and unmet need with clinical importance and public health
implications at a global scale. Cutaneous Neurodiagnostics (CND Life Sciences), a CLIA-certified laboratory,
has developed its core enabling technology of detecting P-SYN in small (3 mm) patients’ punch skin biopsies
and launched the first commercially available diagnostic test for synucleinopathy, the Syn-One Test™. In this
Direct to Phase II study, CND Life Sciences will advance the Syn-One Test™ through detection of P-SYN
in iRBD patients to predict phenoconversion risk and accelerate the commercial viability of testing
through an innovative AI-powered augmented pathological interpretation of the results. To achieve this
objective, CND Life Sciences has conducted feasibility studies to demonstrate that cutaneous P-SYN deposition
can be reliably detected in 94-100% of synucleinopathy patients and in none of the disease control subjects,
while preliminary pilot studies showed that P-SYN is observed in 64% of iRBD patients. In this proposal, CND
Life Sciences will collaborate with the North American Prodromal Synucleinopathy (NAPS) consortium (an NIH-
funded project) to 1) define the metrics of P-SYN deposition and nerve fiber degeneration that predict pheno-
conversion in iRBD patients (Aim 1) and 2) enhance pathological reading through digital quantitative analysis of
the Syn-One Test™ using an AI-augmented detection system (Aim 2). Successful completion of this study will
advance the clinical utility of the Syn-One Test™, improving patient care, increasing the commercial potential of
the product, and ultimately accelerating the development of disease-modifying therapies.

Public health relevance
PROJECT NARRATIVE A group of neurodegenerative diseases, termed synucleinopathies, have no existing disease modifying thera- pies, affect over 2 million people in the U.S. and share an underlying pathology—progressive deposition of phos- phorylated α-synuclein protein in the central and peripheral nervous systems. In the proposed study, CND Life Sciences will advance the diagnostic and commercial potential of its Syn-One Test™ that detects phosphorylated α-synuclein in small skin biopsies by focusing on a population of patients diagnosed with idiopathic rapid eye movement disorder (iRBD), >90% of whom will ultimately develop synucleinopathy 10-15 years following iRBD diagnosis. Successful completion of this study will enable the clinicians to utilize the Syn-One Test™ to deter- mine which of the iRBD patients will develop synucleinopathy, which type and how quickly, and aid in the devel- opment of therapies for this group of devastating diseases.